Shared Resources Core: Ferroptosis Biomarkers and Lipidomic Analysis

Project Summary
Cancer resistance to ferroptosis is often mediated through changes in lipid abundance. Moreover, during
ferroptosis, specific lipids undergo oxidation. Despite the critical importance of lipids in ferroptosis, it is
challenging to assess the abundance and spatial distribution of lipids. Moreover, assessing the presence of
biomarkers of ferroptosis is critical, but it can be challenging to find reliable reagents and conditions for marker
detection. Hence, this technical core will provide bulk and spatial lipidomics capabilities and ferroptosis biomarker
detection capabilities. The core will use DESI-MSI and UPLC-MS/MS for detecting and imaging lipids in human
and mouse samples, and qPCR, western blots and fluorescent reagents for detecting ferroptosis markers.
The core’s workflow uses consecutive sections for analysis of fresh frozen tissue by histological staining, DESI
MS imaging, and UPLC-MS/MS. Additional sections can be generated for complementary analyses, including
bulk and scRNA sequencing, proteomics, and immunostaining of markers.
The core has a leadership team with experience running cores and performing lipidomics and ferroptosis assays,
ensuring high quality service to the program project.
The mission of the core is to support the three research projects in the program project grant by enabling them
to perform bulk and spatial lipidomics and standardized, rigorous ferroptosis marker assays. Each project will be
able to easily access the data, protocols, and analyses used for other projects.
The core will provide innovative experimental design, methods, analysis and data integration workflows.
Together, these will allow the projects to easily and rigorously assess the lipids and markers of ferroptosis
relevant to their goals.
These services will allow the core to provide standardized, state-of-the-art services for key markers related to
ferroptosis in a uniform, robust, and unbiased manner through the entire program project.

Public health relevance
Project Narrative The SR Core will provide bulk and spatial lipidomics capabilities and ferroptosis biomarker detection capabilities; the mission of the core is to support the three research projects by enabling them to detect key changes that occur during ferroptosis in a rigorous and uniform manner without re-developing and re-optimizing the same protocols. Through this support of the research projects in this program, the SR Core will assist in identifying mechanisms of cancer drug resistance and how to overcome this resistance mechanisms, providing new approaches to targeting otherwise difficult to treat cancers.